Physician Scientist Training in Age-Related Diseases

ABSTRACT
The goal of this new T32 post-doctoral training grant is to train exceptional physician-scientists for
independent careers in age-related conditions. We will recruit physician-scientist trainees at the
completion of clinical training and before the initiation of their independent research career. Given the
growing number of older adults globally, the health-related issues of older adults will dominate the health
care landscape. Physician-scientists are well poised to conduct translational research relevant to the older
population as they can appreciate the clinical implications of pre-clinical research and have a unique ability
to identify areas of research likely to have a substantial impact on clinical care. University of Michigan
(UM) is uniquely positioned to train promising physician-scientists in age-related research as UM has
robust programs in geroscience/biology of aging, geriatrics, clinical medicine and health policy research.
To train physician-scientists in translational medicine in age-related conditions, we will include mentors
that represent the spectrum of translational medical research from preclinical research, through to research
in healthy and diseased human subjects (i.e., translational), to public policy and population health. The
Director (Dr. Mody) and the two Co-Directors (Drs. Goldstein and Min) of this program are all physician-
scientists who examine various aspects of age-related conditions across this translational research
spectrum. Dr. Mody is a clinical interventionalist who has active collaborations with investigators who
conduct basic genomic research to scientists in healthcare research policy. Dr. Goldstein examines how
aging impacts inflammation by employing pre-clinical models of atherosclerosis, influenza viral infection,
and organ transplantation. Dr. Min is a health services outcomes researcher with expertise in linking
quality measures and quality improvement with clinical outcomes. Our training program includes faculty
preceptors in each of the pre-clinical, translational and public policy domains. In addition to the individual
expertise of the faculty, our program also will leverage several successful programs at UM including: The
University of Michigan Older Americans Independence Center, the Michigan Institute for Clinical and
Health Research, Biology of Aging, Institute for Healthcare Policy and Research, Michigan Biology of
Cardiovascular Aging and Institute for Social Research. We expect that our new training program will lead
to a cadre of outstandingly trained young physician-scientists who will pursue cutting-edge translational
research in age-related conditions and themselves become mentors and leaders in the field.

Public health relevance
PROJECT NARRATIVE This program will establish a pipeline of outstanding physician scientists in in age-related diseases. We will leverage the considerable resources at the University of Michigan in medical education, biomedical research and public policy as well as a talented pool of preceptors, supported by various NIH-funded centers, to attract physician scientists at the end of their clinical training (post-doctoral trainees). Our multi-disciplinary training program for physician scientists will prepare them for careers in medicine with the ultimate goal to improve the health of the ever-expanding older population.